Sub-second catecholamine dynamics underlying food reward in humans

SUMMARY
The prevalence of obesity in the United States (US) has been consistently rising. For individuals with obesity the
lifetime risk of developing type 2 diabetes (T2D) is 3-7 times greater than for those without. Despite substantial
advances in obesity treatment, obesity and T2D remain global public health challenges. Recent estimates
suggest dietary factors contribute to >300,000 deaths per year in the US, making decisions about what foods to
eat a leading and modifiable driver of disease burden. While changes in brain systems involved in energy balance
and homeostatic regulation are thought to contribute to obesity, importantly, changes in neural systems
associated with attention, reward learning, and affective regulation also occur. These changes may allow reward
systems to override satiety signals and promote eating. Consequently, a detailed understanding of the underlying
neurochemistry of attention, reward, and valence is key to understanding the neurobiology of eating behavior
and obesity. A wealth of literature, largely generated in model organisms, supports the general hypothesis that
alterations in brain catecholamine signaling (i.e., dopamine and norepinephrine release) are key drivers of
food intake and reward-based decision making. The importance of studies in rodents on mechanisms of food
reward, learning, motivation, and by extension the neurobiology of obesity cannot be overstated. However, much
of this literature has not been translated to humans. This represents a fundamental gap in our understanding of
the essential human health behavior of food choice and food reward. The long-term goal of this research is to
provide a framework to translate and extend mechanistic studies of food reward in rodents to humans. To that
end, here we will leverage innovations from our group in two domains: 1. the capacity to detect sub-second
changes in dopamine (DA) and norepinephrine (NE) and distinguish them from each other, 2. the ability to
perform these measurements on electrodes routinely implanted in clinical settings, in this case for phase II
Epilepsy Monitoring. Bringing together a team that combines expertise in human neuroscience of ingestion,
neuromodulation, and computational modeling, we will test the central hypothesis that DA and NE dynamics will
differentially encode aspects of food and non-food reward dependent on body mass index (BMI). In Aim 1, we
will measure catecholamine dynamics from the amygdala during a food-based learning task. In Aim 2, we will
measure catecholamine dynamics from the amygdala during a task using emotion, food, and neutral words.
Completion of this proposal will begin to bridge the translational gap between studies in rodents and humans. It
will also provide a needed foundation for more in-depth testing of the relationship between brain mechanisms of
food reward and peripheral markers of metabolic health and disease.

Public health relevance
NARRATIVE Obesity remodels circuits brain-wide, including areas governing reward, motivation, valence, and cognition. While a robust mechanistic literature supporting the role of brain catecholamine systems in these processes exists in pre-clinical models, translational progress has been hindered by the lack of a technology that can capture the second-by-second neurotransmitter release dynamics that mediate these processes in humans. Here we will perform sub-second measurements of brain catecholamine release in people with and without obesity performing reward tasks to begin to bridge this translational gap.